Engineering Technologies for Acute Trauma Care

PROJECT SUMMARY
Trauma-related injuries, such as from motor vehicle accidents, accidental falls or acts of violence,
are the 3rd leading cause of death in the United States, and the leading cause of death for those
between 1 and 46 years of age. Damage control resuscitation is initiated by first responders to
restore tissue perfusion and oxygen delivery while preventing complications associated with
aggressive resuscitation efforts. However, as most interventions for addressing bleeding rely on
blood product transfusions, limited treatments are available for use outside the hospital setting.
The goal of this proposal is to engineer novel, synthetic therapies for stabilizing trauma victims in
the critical “golden hour” after injury. Our main objectives are to develop low volume resuscitants
that provide fluid resuscitation while preserving the patient’s coagulation system and immune-
modulating polymers that attenuate inflammation and neutralize reactive oxygen species.
Successful completion of these aims will lead to new and critically-needed innovations for trauma
medicine.

Public health relevance
PROJECT NARRATIVE Hemorrhage from trauma-related blood loss accounts for over 3% of global mortality with up to half of the deaths occurring in the prehospital environment. The overarching goal of this project is to develop new therapies for damage control resuscitation and for mitigating trauma-induced inflammation. We anticipate that the proposed research will expand therapeutic options for first responders and improve survival and outcome of trauma victims.